Harnessing tongue exercise to enhance neuroplasticity and preserve upper airway function in a novel model of hypoglossal motor neuron degeneration

Motor neuron diseases (e.g., amyotrophic lateral sclerosis/ALS, pseudobulbar palsy, and Kennedy’s disease)
result in life-threatening alterations in upper airway function (i.e., swallowing and breathing) primarily due to
degeneration within the hypoglossal (XII) axis. This includes upper motor neurons (UMNs) in the orofacial region
of the primary motor cortex (MIo), lower motor neurons (LMNs) in the brainstem, and the tongue muscles.
Despite its critical importance, upper airway function has seldom been studied in motor neuron diseases; thus,
effective treatments remain to be discovered. The fundamental goals of this study are to understand how
XII axis degeneration impairs the function and coordination of swallowing and breathing, and to
determine if (and how) tongue exercise alters XII axis deficits in a novel model of XII motor neuron death.
This unique model is induced by intralingual injection of cholera toxin B conjugated to saporin (CTB-SAP) to
cause XII motor neuron death, decreased XII motor output, degenerative changes in the XII nerve and
genioglossus (muscle innervated by the XII nerve), and corresponding decreased tongue motility and swallowing
rate, thus mimicking aspects of dysphagia in motor neuron diseases. Further, we have exciting new pilot data
suggesting that tongue exercise in CTB-SAP treated rats remarkably preserves tongue strength and motility as
well as swallowing and breathing patterns/coordination similar to controls. Here we will test the central
hypothesis that upper airway function/coordination can be preserved in the face of XII motor neuron
degeneration by harnessing the therapeutic potential of tongue exercise to upregulate neuroplasticity
via neurotrophic factor expression in spared XII axis motor neurons. We will test this hypothesis in our
novel CTB-SAP rat model using a translational, non-invasive therapeutic strategy of resistance tongue exercise
training, and a multidisciplinary approach involving whole body plethysmography, videofluoroscopic swallow
studies, force lickometer testing, XII nerve and evoked swallowing electrophysiological recordings, in vivo
pharmacological manipulations, histological assessments (immunohistochemistry and transmission electron
microscopy), and neuroimaging (magnetic resonance imaging). Two specific aims are proposed after intralingual
CTB-SAP injections to determine: 1) how swallowing and breathing patterns/coordination are altered by XII axis
degeneration; and 2) the impact of tongue exercise on XII axis deficits and the role of neurotrophic factors. Since
most patients with motor neuron disease develop upper airway dysfunction leading to ventilator and/or feeding-
tube dependence, our long-range goal is to develop new strategies to enhance the functional capacity of spared
XII motor neurons to improve functional outcomes. If successful, this work will identify behavioral (tongue
exercise) and molecular (e.g., neurotrophic factor) strategies for future translational studies to preserve upper
airway function in patients with motor neuron diseases to significantly improve the quality and duration of life.

Public health relevance
Functional deficits of tongue movement have a profound impact on upper airway function (swallowing and breathing), often leading to aspiration pneumonia and respiratory failure in motor neuron diseases; however, there are currently no effective treatments to preserve upper airway function in the face of motor neuron degeneration. Using a non-invasive therapy (tongue exercise) targeting hypoglossal motor neurons that provide motor commands from the brain to the tongue, we can harness plasticity in spared hypoglossal motor neurons and repair functional deficits in a novel model of hypoglossal motor neuron death. This project may lead to translational studies to positively increase the quality and duration of life by preserving the function and coordination of swallowing and breathing in patients suffering from hypoglossal motor neuron degeneration.